A Mixed-Methods Study of Novel Housing Programs and Overdose Outcomes Among Unhoused People Who Use Drugs in San Diego, California

Project Summary
As the United States continues to experience growth in both homelessness and drug overdose deaths
among this population, many urban municipalities have instituted new programs aimed at reducing the
visibility of homelessness, including street encampments. These programmatic measures include police-
enforced involuntary displacement and temporary rapid shelters such as “safe camping” sites, so-called
“tiny homes”, and motel room accommodations. While limited research has shown that some of these
programs may negatively impact the health of unhoused people who use drugs (PWUD), little is known
about how they may ultimately impact overdose risk and incidence. This proposed study seeks to
contribute new knowledge about this association using a sequential mixed methods approach in three
phases. In Aim 1, I will use secondary data from the La Frontera cohort study in a longitudinal analysis of
involuntary displacement and housing program exposures on overdose outcomes; in Aim 2, I will
qualitatively explore these associations and gather participant opinions on how housing programs could be
improved via 60 in-depth interviews with 30 PWUD and 30 professional key informants; in Aim 3, I will
collate data from the previous two aims alongside published literature to construct a mathematical model
to predict future overdose incidence across several potential scenarios. I am a well-qualified candidate
with the skills to undertake the proposed research and associated training. I have a strong background in
both qualitative and quantitative work. During the course of the five-year award period, I will undertake five
training goals: 1) gain expertise in the epidemiology of drug overdose, 2) build skills in the design and
conduct of mixed methods studies, 3) acquire training in mathematical modeling of epidemics and
overdose, 4) obtain expertise in the ethical conduct of research with marginaliz ed and vulnerable
populations, and 5) further build my professional career development skills that will prepare me for a
career as an independent academic researcher. To achieve these training goals and complete the
proposed research, I have assembled a team of mentors and contributors with expertise and career
accomplishments in all training areas – substance use and overdose epidemiology, mixed-methods
research, mathematical modeling of infectious disease, and research ethics with vulnerable populations.
Under the guidance of my mentorship team, I will engage in activities including coursework at UCSD,
workshops and seminars at multiple external institutions, submit to and attend both national and
international conferences, and conduct the proposed research. Few researchers possess expertise in
these combined topical and methodological areas, and completion of this work will contribute significantly
to our understanding of how homelessness programming and policy influences overdose risk. These
findings may help shape future evidence-based programming and policy efforts.

Public health relevance
Project Narrative Through this mentored career development award, I will examine the impact of involuntary displacement and rapid shelter programs on fatal and nonfatal drug overdose among a San Diego, California based population of people who use drugs (PWUD). I will then use this data to build a mathematical model that predicts future overdose incidence under various housing scenarios. Results of this study may be useful for informing new housing programming that preserves the health of vulnerable populations like PWUD.